Analyzing DNA replication and damage vulnerability in IDH mutant glioma

Project Summary
Adult diffuse gliomas that harbor mutations in the metabolic enzyme isocitrate dehydrogenase 1 (IDH1) are
common in younger adults, and universally evade the current aggressive therapies and remain lethal. Our team
led by Co-PIs Drs. Cahill and Wakimoto have identified unique metabolic dependencies and combinatorial
therapeutic strategies for IDH-mutant glioma. We have found that poly(ADP-ribose) polymerases (PARP)
activation induced by the alkylating chemotherapeutic temozolomide can be therapeutically exploited by
inhibition of the PAR breakdown enzyme poly(ADP-ribose) glycohydrolase (PARG), resulting in aberrant PAR
accumulation and catastrophic NAD+ depletion. In parallel, PARP “trapping” inhibition has been found to be
synthetic lethal with IDH1 mutation, exploiting a replication-stress mechanism convergent with BRCA1-mediated
homologous-recombination deficiency. However, systemic hematologic toxicities have limited the PARP inhibitor
dosing in glioma patients. Therefore, the goal of our R01 application is to dissect the PAR-driven signaling
pathways in IDH mutant gliomas, providing a mechanistic understanding in malignant glioma cells of the
mediators of sensitivity, to maximize cancer cell targeting and minimize systemic toxicities, ultimately
accelerating translation of laboratory discoveries to the clinic. Focal radiation therapy is part of standard care for
gliomas and an its enhancement is an unmet need. Radiation also offers the opportunity to overcome the
systemic toxicities associated with TMZ-based combination therapies. Aim 1 will determine how radiation
therapy-induced DNA damage and PAR-ylation co-operates with PARG inhibition in IDH mutant tumor models
in vitro and in vivo. Employing genetic and pharmacological inhibition of PARG, we will determine the therapeutic
effects and molecular mechanisms of PARG inhibition in preclinical models of glioma. Mechanistically, PAR
signaling activation can drive multiple downstream molecular pathways including NAD+ depletion, replication
stress, DNA damage and AIF-MIF-driven parthanatos, all of which can contribute to cell death. Aim 2 will
determine whether signaling downstream of PAR polymers directly contributes to cell death after treatment with
alkylators and PARG inhibition to understand the molecular basis of the combination of TMZ and PARG inhibition.
Our ongoing research has revealed that genotoxicity-triggered aberrant PAR-ylation perturbed DNA replication
stress checkpoint signaling in IDH-mutant tumors, motivating us to investigate the ability of potent, selective,
clinical DNA-PKcs inhibitors to disable radiation-induced replication stress responses in Aim 3. The successful
completion of these specific aims will open new avenues for targeting the specific vulnerabilities of IDH1 mutant
gliomas, driving potential clinical therapies for patients with these tumors.

Public health relevance
Project Narrative We propose to explore the mechanisms underlying poly(ADP-ribose)-signaling in IDH mutant gliomas to develop modalities that selectively target these tumors. Our application is relevant to public health because IDH mutant gliomas are common in younger adults, and universally evade the current aggressive therapies and remain lethal, necessitating the identification of novel therapeutic approaches. Relevant to the NCI mission, the objective of this study is to understand sensitivities to specific signaling pathway perturbation, to inform strategies that can improve the efficacy of novel targeted and existing therapies.